Defining the larval repertoire of Aedes aegypti somatosensory neurons

PROJECT SUMMARY
Somatosensory neurons shape an animal’s experience of the world, allowing for perception and
discrimination of temperature, touch, pressure, pain, and movement. Perception of these stimuli
depends on cell type-specific behaviors of somatosensory neurons: innervation of discrete territories
peripherally, projection to stereotyped locations centrally, selective expression of ion channels and
sensory receptors, and choice of appropriate synaptic partners. Despite the importance of
somatosensory neurons to sensation and motor control in all animals, we have a limited
understanding of somatosensory neuron morphology, diversity, and function in Aedes aegypti, a
major vector of human diseases. In this application we aim to close this important gap in knowledge,
leveraging our expertise in insect somatosensory neuron development to anatomically and
molecularly define the repertoire of somatosensory neurons that innervate the Aedes body wall.
central hypothesis is that different types of somatosensory neurons mediate different sensory
Our
modalities, and that features of cell types will be manifest in morphology and gene expression
patterns. Using a robust pipeline we developed for RNA-Seq expression profiling coupled to high
resolution imaging of peripheral innervation patterns we aim to provide a comprehensive map of
Aedes somatosensory neuron diversity.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because this work will yield fundamental insight into somatosensory neuron identity and diversity in Aedes aegypti, a major vector of human disease. Given the importance of somatosensory neurons in sampling sensory cues relevant to navigating the sensory world and locating hosts, the current lack of knowledge about somatosensory development, diversity, and function in Aedes aegypti represents a major gap in our knowledge of this organism which exerts enormous impacts on human health. Thus the proposed research is relevant to the NIH’s mission that pertains to developing fundamental knowledge that will help to reduce the burdens of human diseases.